AI-Enabled Echocardiographic Biomarkers and Real-World Data for Predicting Cancer Therapy-Related Cardiac Dysfunction

Abstract:
Cancer survivors have up to a 42% higher risk of cardiac dysfunction than non-cancer populations, in part due
to sequelae of cardiotoxic cancer therapies—collectively termed cancer therapy–related cardiac dysfunction
(CTRCD). Yet current surveillance strategies suffer from low sensitivity, poor reproducibility, and lack of
personalization. This proposal aims to transform cardio-oncology care by integrating FDA-cleared artificial
intelligence (AI) echocardiographic biomarkers with real-world electronic health record (EHR) data to improve
early detection and risk stratification of CTRCD. Leveraging a diverse cohort of over 34,000 patients treated
with cardiotoxic therapies within an integrated healthcare system with comprehensive data, we will apply
validated AI models to archived echocardiograms to identify subclinical cardiac dysfunction and develop
predictive models that guide personalized surveillance. Specific aims include: (1) evaluating AI-derived
biomarkers for early and standardized detection of CTRCD, and (2) developing and validating multimodal
predictive models combining AI-echo and EHR data. This work will generate regulatory-grade evidence to
inform FDA guidance, improve clinical outcomes, and establish a scalable framework for cardio-oncology
surveillance in real-world settings.

Public health relevance
Project Narrative: Cardiotoxicity from cancer therapies is a growing threat to survivorship, yet current tools fail to identify high-risk patients early enough to intervene. This project uses FDA-cleared artificial intelligence to extract precise cardiac biomarkers from echocardiograms and combines them with real-world clinical data to build predictive models for cancer therapy–related cardiac dysfunction. The results will improve early detection, guide personalized monitoring, and inform FDA regulatory strategies—ultimately enhancing the safety and effectiveness of cancer care for millions of Americans.